RANDOMIZED CONTROLLED TRIAL OF ANGIOGRAPHY ALONE VS DOPPLER SONOGRPHY

To define the utility of Angiography vs Doppler Sonography and Endoscopy Dictated Angiography for the prevention of recureent variceal hemorrhage following transjugular intrahepatic portasystemic shunts by directly comparing the frequency of variceal hemorrhage and other portal hypertension-related complications in patients followed by these approaches after TIPS